ACUTE EFFECTS OF AEROSOLIZED AMILORIDE IN CYSTIC FIBROSIS AND NORMAL SUBJECTS

This project will serve to explore several issues: 1. the capability of the aerosol system to deliver amiloride to the preferred airway regions; 2. the possible dose-response safety of aerosolized amiloride in normal and CF subjects; and 3. the quantity of amiloride deposited and the rate at which the drug is cleared from the airway surfaces. The results obtained from this study will provide information crucial to the design of subsequent aerosolized amiloride studies in CF subjects.